Understanding Store-Operated Calcium Signal Transduction

Project Summary
The remarkable spatial and temporal precision of Ca2+ signals finely controls a vast array of cellular functions.
Ca2+ signals reflect the function of highly coordinated Ca2+ sensors and Ca2+ channels. The interaction between
Ca2+ sensor STIM proteins in the ER and Orai Ca2+ channels in the PM, is crucial in Ca2+ signal generation. The
two proteins physically couple in ER-PM junctions, mediating “store-operated” Ca2+ signals, essential in
controlling gene expression, secretion, motility and growth. Their role in Ca2+ signaling is critical, and defects in
STIM or Orai proteins cause a spectrum of disorders including severe combined immunodeficiency, muscular
hypotonia, autoimmunity, skin dysplasia, and exocrine defects. Dysregulation of STIM/Orai expression is closely
linked to cardiovascular and airway remodeling, neurodegenerative disorders, altered immunity, and cancer. We
have defined much on the molecular properties and cellular organization of STIM and Orai proteins. We now
turn toward the nanoscale ER-PM junctional environment in which they operate. Junctional Ca2+ is critical in
generating both “local” Ca2+ signals and in sustaining “global” Ca2+ oscillations that extend across the cytoplasm
and penetrate the nucleus. Using a compendium of molecular probes, imaging technology, gene-deleted cellular
systems, and animal knockout models, our work is directed toward three major areas: (1) Identifying critical
differences in the disease-related STIM and Orai isoforms, focusing on operation of the widely expressed
STIM2.1 splice variant of STIM2 that lacks the critical Orai-binding domain; using super-resolution STED
microcopy and TIRF/FRET imaging we explore a model by which STIM2.1 disrupts the cross-linking of Orai
channel subtypes within junctions, and determine how clustering organizes the junctional Ca2+ signaling
machinery. (2) Defining the micro-physiological environment of Ca2+ entry junctions, utilizing genetically encoded
and optogenetically applied Ca2+ probes tagged onto STIM and Orai proteins to monitor the highly restricted
junctional Ca2+ micro-environment; using such measurements to explore how STIM-mediated clustering of Orai
channels controls local junctional Ca2+ signals, modifies the proximity of InsP3Rs and SERCA pumps, and
modulates the generation of global Ca2+ oscillations. (3) Understanding how store-operated Ca2+ signals are
transcriptionally transduced, exploring how the “STIM2 phenotype” in smooth muscle- and B cell-targeted
STIM1-deleted animals is related to STIM1/STIM2.1 expression levels and junctional Ca2+ signals, how STIM-
modulated Orai clustering controls specific NFAT subtype activation, and determining transcriptome changes
related to STIM type-specific Ca2+ signal generation. Our studies address the critical gap in our knowledge of
how junctional Ca2+ tunes the generation of local and global Ca2+ signals. The central role of STIM/Orai-mediated
store-operated Ca2+ signals in cell physiology, the widespread dysfunction caused by STIM/Orai mutations, the
deep functional distinctions between STIM/Orai subtypes, and the extraordinary alteration of subtype expression
in major disease states, all define the STIM-Orai interface as a pivotal therapeutic target.

Public health relevance
Project Narrative Calcium signals are crucial in controlling the function of cells in the entire body. We study the basic mechanisms that generate and control calcium signals, and use immune cells and vascular smooth muscle cells since they are good model systems for understanding the molecular mechanisms of calcium signaling. The work focuses on understanding two proteins that are essential in giving rise to calcium signals. These two proteins, STIM and Orai, have very different function, but come together in special junctions in the cell, to trigger the entry of calcium, giving rise to important signals that regulate growth, metabolism, and many other cell functions. Our aims are to understand the molecular mechanism of calcium signals and how the calcium signaling machinery functions so that we can determine ways to control the signals and allow the development of new agents and drugs that can prevent and cure cardiovascular and immunological disease.